Mechanism and Modulation of the homeostatic setpoint for protein feeding

Project Summary
All animals share motivated behaviors to fulfill their basic needs for survival, including food, water,
sleep, and social interactions, etc. The homeostatic regulatory system energizes behaviors to defend a
target level for these needs (the homeostatic setpoint). For example, human adults, on average, aim to
sleep 7-8 hours daily. What defines the homeostatic setpoint and how is it modulated remain
unanswered questions for all motivated behaviors. Do dedicated neural circuits exist that determine the
setpoint? How are changes in physiological needs detected and translated into modified setpoints?
These questions have been difficult to address, largely due to a lack of simple manipulations that
rapidly and profoundly change the homeostatic setpoints. Protein is a crucially important macronutrient,
and behavioral studies indicate that a wide range of species, including humans, seek to consume a
fixed amount of protein: the protein intake target. In Drosophila fruit flies, mating induces a robust
increase for the consumption of protein-enriched food in pregnant female flies, due to the greater need
for protein in egg production. That change in needs rapidly reset the protein intake target and thus
provides an elegant model to study the homeostatic setpoint for motivated behaviors. Using Drosophila,
we recently identified and characterized the first neural circuit encoding protein-specific hunger. In this
proposed study, we seek to delineate the circuit and molecular mechanisms underlying the
determination and modulation of the protein intake setpoint. Specifically, we plan to 1) test the
hypothesis that the protein intake setpoint is encoded in the hunger neurons by the membrane
excitability; 2) identify the neural circuit feeds into the hunger neurons and resets the protein intake
target; and 3) elucidate the molecular sensors detecting the changes of protein needs. To achieve
these goals, we will employ a multidisciplinary approach, including large-scale genetic analyses,
quantitative behavioral measurements, immunohistochemistry, patch-clamp electrophysiology, and
functional imaging. These investigations will shed light on the fundamental principles underlying the
organization and modulation of homeostatic setpoint for motivated behaviors.

Public health relevance
Project Narrative How homeostatic setpoints are determined and represented in the brain remain unanswered questions for all motivated behaviors. In this proposed study, using mating induced resetting of protein intake target in Drosophila as a model system, we aim to elucidate the circuit and molecular substrates mediating the determination of homeostatic setpoint. This study should provide insights into the fundamental principles for the organization and modulation of homeostatic setpoint for motivated behaviors.